T32 Cincinnati Pediatric Clinical Pharmacology Training Program

PROJECT SUMMARY
This is a competitive renewal application for the continuation of a highly collaborative and successful pediatric
clinical pharmacology training program at Cincinnati Children's Hospital Medical Center and the University of
Cincinnati. The program will train a new generation of pediatric investigators to assume leadership roles in the
application of innovative, high impact quantitative clinical pharmacology approaches to improve the
development, rational use and tailoring of new and existing drug therapies for neonates, infants, children,
adolescents and young adults. The need for pediatric clinical pharmacology research and training has never
been greater. The T32 Training Program in Pediatric Clinical Pharmacology at Cincinnati Children's Hospital
Medical Center (CCHMC) is designed specifically to address this critical need. The program is based in the
Division of Clinical Pharmacology, which is jointly a unit within the Department of Pediatrics and the University
of Cincinnati, College of Medicine (UCCoM). The program outlined in this renewal application draws on strong
leadership and a diverse group of well-established faculty mentors actively involved in subspecialty clinical
pharmacology research, representing 18 divisions within the Department of Pediatrics, the Departments of
Pharmacology & Systems Physiology and Biomedical Informatics at the UCCoM, and the James L. Winkle
College of Pharmacy. The program has tremendous institutional support and takes advantage of broad areas
of distinction and resources within a uniquely collaborative environment. The T32 training program is
innovative and well aligned with the objectives outlined in the program announcement as it: (1) has a focus in
early and later phase studies in multiple and diverse pediatric populations through ongoing research
collaborations with all major pediatric subspecialties; (2) involves the application and development of
innovative quantitative methodologies such as PK/PD modeling and pharmacometrics, quantitative systems
pharmacology modeling and simulation and model-informed clinical trial design; (3) is embedded in the
institutional and UCCoM pharmacogenetic/genomics research and training endeavors through the Center for
Pediatric Genomics; (4) is closely integrated with Bioinformatics and Health Services and Outcomes Research;
and (5) can rely on over 10 years of a well-established curriculum after two funding cycles as a successful
training program. The program provides a unique training experience to MDs, PharmDs, and PhDs to become
the next generation of leaders whose work will advance pediatric clinical pharmacology and to have an
extraordinary impact on pediatric therapeutics and health outcomes for children. The program has successfully
opened new avenues to enlarge the pool of talented young clinical investigators with a career interest in
pediatric therapeutics.

Public health relevance
Narrative The Cincinnati T32 Training Program in Pediatric Clinical Pharmacology provides an outstanding resource for expanding and improving the current critically small pool of pediatric clinical pharmacologists by training the next generation of pediatric clinical investigators to assume leadership roles in developing innovative, high impact clinical and developmental pharmacology related approaches that will be transformative to how we use medicines in children. This will allow the implementation of personalized pediatric therapeutics and improve the quality of care and related health outcomes of children.